Penn Center for Study of Epigenetics in Reproduction

The Penn Center for the Study of Epigenetics in Reproduction (PennCSER) will elucidate epigenetic
mechanisms that govern male and female reproduction, contribute to male infertility and impact development
of mouse and human concepti conceived through assisted reproductive technologies (ART). The PennCSER
centerpiece is 4 integrated, innovative research projects, spearheaded by experienced leaders in the areas of
epigenetics and reproduction. The Center also features an Outreach program that has been in place for more
than 5 years; the Penn Academy of Reproductive Sciences uses hands on laboratory experiences and
interactive lectures to educate high school students, largely from the Philadelphia area schools, in the
reproductive sciences. The clinical project (Project 1, Coutifaris, Sapienza, Mainigi and Senapati) will assess
the impact of the periconceptional maternal environment on DNA methylation and gene expression in
embryonic (placental vessels and endothelial cells) and extra-embryonic (trophoblasts) tissues in IVF
pregnancies following fresh or frozen transfer, pregnancies resulting from unassisted conception and
pregnancies following trophectoderm biopsy for pre-implantation genetic testing for aneuploidy (PGT-A). This
project will also determine the stability of epigenetic signatures determined at birth into childhood and correlate
them with the children’s growth phenotype. Project 2 (Bartolomei, Mainigi, Schultz) will closely parallel Project
1 using a validated mouse model to study the effect of ART laboratory manipulations on epigenetic gene
regulation and physiological outcomes in term conceptuses and adults. Project 2 will address the question of
whether embryo freezing and transfer to an unstimulated uterus is optimal and evaluate the safety and
outcomes associated with trophectoderm biopsy. Project 2 will also test whether decreased expression of
Grb10, a growth-regulatory imprinted gene overexpressed in human and mouse ART-derived conceptuses,
can rescue ART-associated phenotypes in a mouse model. Project 3 (Berger) will investigate histone
modifications during mouse spermatogenesis and determine their conservation in normal human sperm and
disruption in abnormal human sperm, as well as in mouse models exhibiting abnormal histone retention.
Project 4 (Wang and Masson) will examine the function of TEX15, a protein that is required for meiosis and
male fertility, and is a novel epigenetic regulator essential for retrotransposon silencing. Project 4 will also
determine whether aberrant retrotransposon activity is associated with male infertility. PennCSER will not only
provide training to clinicians, physician scientists, and basic research fellows in the area of epigenetics but also
provide PennCSER’s expertise to the NCTRI and associated program members.

Public health relevance
PennCSER will provide cutting edge expertise in the area of epigenetics of reproduction that will rapidly translate into treatment of human infertility, bring further expertise to the NCTRI program, train the next generation of reproductive biologists, including physician scientists and basic research scientists, and educate the lay public and high school students about the reproductive sciences.